Inhibition of Regeneration Restraining Pathways to Promote Healing

Project Summary Abstract
The long term objective of the proposed research is to enhance healing after injury that is often slow and
incomplete. We hypothesized that injury to epithelial tissue like skin and gut share commonalities in healing,
with some native injury responses which actually restrain healing. The goal of this grant is to define the
mechanism of this restraint in hopes of developing therapies to enhance healing. We will test if inhibition of
these pathways that restrain healing can improve regeneration after injury or infection to the gut or skin in the
hopes of suggesting a new class of therapeutics to aid healing from diverse injuries.

Public health relevance
Project Narrative Our body's response to a wound is often inadequate; it is often slow and incomplete without true regeneration. We hypothesize that many distinct forms of organ injury like wounds or infection have common elements in healing, and even unappreciated ways these elements actually restrain rather than promote optimum healing. By inhibiting this restraining pathways that prevent optimum healing, we hope to create new therapeutics to help recovery from injury or infection.